Enriching and Base-Resolution Profiling of 5-Methylcytosine in Degraded Clinical Samples

PROJECT SUMMARY
The epigenome, centered around 5-methylcytosine (5mC), carries ample molecular signatures for
understanding, detecting, and tracking tumorigenesis. However, 5mC profiling in clinical samples, such as
formalin-fixed, paraffin-embedded (FFPE) tissues and cell-free DNA (cfDNA), is hindered by their limited quantity
and degraded DNA. To address these challenges, this proposal describes development and application of the
first glycosylase-based epigenome-sequencing platform. With superior sensitivity and fidelity, glycosylase-
implemented epigenome sequencing (Glimp-seq) is poised to uncover the molecular underpinnings of
tumorigenesis in low-volume degraded samples.
Glimp-seq harnesses cascade enzymatic reactions involved in mammalian active demethylation—5mC
oxidization by ten-eleven translocation dioxygenase (TET) and 5-carboxylcytosine (5caC) excision by thymine
DNA glycosylase (TDG)—to convert 5mC into abasic sites. These abasic sites are subsequently functionalized
by a thymine mimic to facilitate 5mC-specific enrichment and direct mutation detection (5mC-to-T). Glimp-seq
represents a major advancement over current epigenome profiling methods, including bisulfite sequencing (BS-
seq), enzymatic methyl sequencing (EM-seq), and TET-assisted pyridine borane sequencing (TAPS), by
employing gentle, yet efficient, enzymatic conversions that preserve DNA integrity. As the specificity of the
cascade TET/TDG reactions has been extensively optimized during natural evolution, Glimp-seq achieves
unparalleled specificity for 5mC, reducing the risk of false positive detection. Unlike existing methods, Glimp-seq
uniquely supports sequence-independent 5mC-specific enrichment, thereby increasing detection sensitivity. The
resulting superior sensitivity and fidelity make Glimp-seq particularly suited for 5mC profiling in degraded clinical
samples.
In Aim 1, we will develop and rigorously benchmark Glimp-seq, using both synthetic and genomic DNA
samples. We will compare Glimp-seq with BS-seq, EM-seq, and TAPS, and demonstrate its superiority using
quantitative metrics. In Aim 2, we will apply Glimp-seq to two sets of clinical samples: ~140 FFPE cancer tissues
from patients of prenatal exposure to diethylstilbestrol (known as DES daughters), which provides a unique
opportunity to investigate synthetic estrogen-induced epigenetic inheritance; and cfDNA from 50 colorectal
cancer patients, to showcase non-invasive detection of cancer-associated 5mC signatures. Successful
implementation of Glimp-seq will transform the clinical practice of epigenome profiling by facilitating mechanistic
studies using FFPE samples and by expediting early cancer diagnosis through cfDNA analysis. By freely
distributing Glimp-seq reagents and protocols, we aim to support cancer researchers both locally and globally,
fostering continuous advancements in understanding, detecting, and tracking cancer.

Public health relevance
PROJECT NARRATIVE The epigenome carries ample cancer signatures, but their detection in clinical samples, such as formalin- fixed, paraffin-embedded (FFPE) tissues and cell-free DNA (cfDNA), is hindered by the limited quantity and poor quality of DNA. To overcome this challenge, we propose to map cancer-associated 5-methylcytosine, the most abundant epigenetic modification in the human genome, through novel enzymatic conversions. Successful launch of our technology will transform the clinical practice for epigenome profiling, facilitating mechanistic studies using FFPE samples and expediting early cancer diagnosis using cfDNA.